Development of End-To-End Clinical Decision Support Tools To Prevent Cardiotoxic Drug Response

SUMMARY
Drug-induced cardiac toxicity, in the form of QT prolongation and torsade de pointes, is an uncommon but
devastating side effect of over one hundred currently marketed drugs. The ubiquity of drug-induced QT
prolongation (diLQTS) across medical specialties and conditions creates a challenge for providers seeking to
prescribe known QT-prolonging medications, particularly for non-cardiac conditions. Work by our group to
develop automated clinical decision support (CDS) tools that alert providers of patient risk has shown promise
towards reducing the number of prescriptions to at-risk individuals. However, these tools rely on a history of an
electrocardiogram (ECG) with QT prolongation to identify at-risk patients, and thus exclude a large number of
potentially at-risk individuals who have not had an ECG within our system. Through a unique institutional
partnership with Google, in which a copy of our entire electronic health record (EHR) is stored on the Google
Cloud Platform (GCP), we have developed preliminary deep-learning models to predict risk of diLQTS. We
have also validated the genetic association with the QT interval and diLQTS across several real-world
populations using an aggregate polygenic risk score. Through creation of an institutional biobank with
certification for clinical application of results, as well as cloud-based integration of EHR data with genetic data,
we have the capability to leverage our existing infrastructure to study the role of deep learning and genetics to
reduce the risk of diLQTS. This investigation will combine our unique research and clinical
infrastructure on the University of Colorado Anschutz Medical Campus with our investigative team
composed of experts in the study of pharmacogenomics and medical informatics to develop and study
an end-to-end CDS tool incorporating genetics and deep learning to predict risk of diLQTS. The
specific aims of this application include the following: (1) develop and test a cloud-based, deep-learning model
using EHR data on in- and outpatients to predict risk of diLQTS; (2) validate genetic predictors of diLQTS using
institutional biobank samples, and a multi-ethnic external population; and (3) develop and test CDS tools using
these advanced methods to reduce the risk of diLQTS. We will use a common data model (Observational
Medical Outcomes Partnership) mapped from EHR data, as well as a custom DNA array (Multi-Ethnic
Genotyping Array) designed for imputation across a variety of non-European ancestries, to ensure that the our
prediction model and findings from this study can be replicated in other institutions and populations in the
future. In such a way, this investigation will not only provide insight into the use of machine learning and
genetics for risk prediction of diLQTS, but it will also create a blueprint for future advanced CDS development
for other conditions.

Public health relevance
PROJECT NARRATIVE The goal of this project is the development of a clinical decision support tool that can be used to predict the risk of drug-induced QT prolongation based on deep learning and genetics. This tool could be used to prevent potentially fatal side effects of medications when alternatives are available, or increase vigilance when safer alternatives are not available. This study is specifically designed so that the models created can be directly applied across other institutional medical record systems beyond the study population.